Discovery of novel phage-bacterial interactions

PROJECT SUMMARY
Interactions between bacteria and their viruses (phages) are among the most ubiquitous in nature and have
yielded transformative tools for genetic engineering, such as restriction enzymes and CRISPR-Cas. More than
three dozen new bacterial immune systems have recently been discovered across many bacterial species.
Some of these immune systems, such as CRISPR, target phage for cleavage, while others sense phage
infection and induce bacterial death to halt phage spread. In turn, phages express “anti-immune” proteins to
disarm these bacterial defenses, including “anti-CRISPR” (Acr) proteins that inhibit Cas effector functions.
Phage-derived interactors (either inhibitors or activators) have not yet been found for most of these immune
systems, however.
The long-term objective of this proposal is to identify phage proteins that interact with or trigger activation of
these immune systems. These interactions will be identified using yeast two hybrid screens and validated
using affinity purification-mass spectrometry analysis in bacteria. In the two-hybrid screen, the Gal4
transcription factor will be split into an activation domain and DNA-binding domain and fused to each phage
“prey” protein and bacterial immune “bait” protein, respectively. Interaction between the prey protein and bait
protein should reconstitute the full transcription factor and enable expression of a reporter gene that confers
survival on selective media. Rationally selected phage proteins will be screened for interactions with CRISPR-
Cas proteins as well as immune proteins that lack known interactors. This versatile platform will accelerate the
discovery of phage-bacterial interactions, which have long transformed molecular biology and gene therapy.
In parallel, the strategies that phage use to inactivate CRISPR-Cas systems in bacteria will be applied to gene
therapy in human cells to reduce cytotoxicity and off-target effects. Phages that constitutively inactivate Cas9
and Cas12a in bacteria often block both targeting and expression, which is likely optimal for long-term Cas
inactivation. Mammalian gene editing performed with Cas9 delivered on viral vectors often causes off-target
mutations and cytotoxicity associated with long-term Cas9 expression. To mitigate these off-target effects,
strategies to inactivate CRISPR-Cas complexes and reduce their expression (after on-target editing has
occurred) will be combined and compared. This work will be performed at UCSF, which hosts world-class
facilities and a highly intellectual and collaborative research community. It will also provide me with the
expertise in protein-protein interaction screens and gene editing that I need to fulfill my postdoctoral training
goals and pioneer an independent research program in bacterial-phage interactions.

Public health relevance
PROJECT NARRATIVE Many of the tools used in gene therapy and biomedical research (e.g. CRISPR-Cas systems) were discovered by studying bacteria and their viruses. This work will identify new regulators for CRISPR-Cas systems and compare different strategies to reduce their undesired off-target effects. This work will also find new bacterial- viral interactions that may influence biomedical and research technologies in years to come.